Integrated Biological Systems Training in Oncology

PROJECT SUMMARY
The Integrated Biological Systems Training in Oncology (IBSTO) program was established in 2008, with the
objective of providing pre-doctoral students and post-doctoral fellows with cancer-focused training that
integrates basic biological processes and translational research through understanding of the approaches
and model systems that fuel cancer discovery. The IBSTO philosophy is that future breakthroughs in the
diagnosis, prevention, and treatment of cancer will most likely be made by those individuals who are facile in
a broad suite of methodologies and approaches, who understand the importance of collaboration and cross-
disciplinary research, and who can bridge the divide between basic scientific discovery and clinical
implementation. The IBSTO program takes place in a vibrant and inclusive cancer-forward research
environment with superb resources, state-of-the-art facilities, top-ranked basic science departments, an
outstanding NCI-designated comprehensive cancer center, and world-class basic and translational
researchers and physician-scientists. Since its inception, we have recruited a diverse and outstanding cohort
of more than 60 pre- and post-doctoral trainees, researching in the laboratories of well-funded and productive
preceptors in a wide range of areas including cell biology, genetics, biochemistry, structural biology, cancer
immunology, computational and systems biology, single cell approaches, omics, and translational cancer
research. Productivity and outcomes for IBSTO trainees—both short and long term—are superb. In this third
renewal application, we fortify our traditional areas of training strength and introduce a number of exciting and
innovative new initiatives that keep this program fresh and effective. Four pre- and four post-doctoral trainees
will spend two years each in the program, receiving a foundational training in cancer biology, sharing their
discoveries, being exposed to the latest in basic and translational cancer research, and receiving intensive
training in grant writing, scientific and lay communication, and career building. A new career series "Cancer
Research Journeys" will provide first-hand exposure to the interplay between scientific discovery and
professional development in the cancer realm. A new signature course "Scientific Exposition, Ethics, and
Equity in Cancer Research" will coach skill building through the lens of communication and interactivity, and
teach the tools, approaches, and strategies needed for an impactful career that contributes to the amelioration
of cancer. A streamlined administrative structure will keep the program nimble, and reinforce our commitment
to diversity, equity, and inclusion. And a new program co-Director will further our efforts in this regard, bring
new ideas and energy, and position IBSTO for continued success in the next period and beyond.

Public health relevance
PROJECT NARRATIVE The Integrated Biological Systems Training in Oncology (IBSTO) program, begun in 2008, prepares pre- doctoral students and post-doctoral fellows for careers in cancer research by comprehensive training in basic and translational oncology, communications, and career building. The IBSTO program takes place in a world- class cancer research environment with state-of–the-art facilities, experienced preceptors, extensive resources, and strong institutional support. The long-term mission of the IBSTO program is to advance inclusive excellence in cancer research and to enable and empower a diverse population of talented trainees to pursue diverse and impactful career paths that contribute to the amelioration of cancer.